Porcine Platforms For Technology Development In Pancreatic Cancer

Porcine Platforms For Technology Development In Pancreatic Cancer
PROJECT SUMMARY/ABSTRACT
The long-term goal of this research is to develop a platform on which experimental therapies and devices for
pancreatic cancer (PC) management can be advanced to the clinic in a more efficient manner than achievable
with current preclinical PC models. The focused objective of this R01 application is to demonstrate the utility of
a transgenic porcine model of cancer (the KRAS/p53 Oncopig) in testing the antitumor efficacy of novel
neoadjuvant therapies and also in testing the effectiveness of three endoscopic medical devices for imaging and
treatment of PC. Murine PC models may not adequately reflect human tumor biology because of differences in
size, physiology, anatomy, and genetic sequence with humans. So, the rationale to use a porcine model of PC is
that it should be more predictive of human tumor biology and response to therapy than murine models are.
This R01 application will particularly use the swine's size advantage. The hypothesis of this R01 application is
that transgenic porcine models of PC are feasible and useful for testing of PC applications. In Aim 1, the ability
of the transgenic porcine PC model to replicate the entire neoadjuvant therapy/surgery/survival sequence of
human PC management will be demonstrated. In Aim 2, two novel endoscopic technologies for imaging and
treatment of PC will be tested in the Oncopig, in studies which would not be feasible in a mouse. The work
proposed in this R01 application will be accomplished through a collaborative, multi-faceted team that will
include a general-oncologic surgeon (PI), molecular/cellular biologists with expertise in PC and gene editing, a
medical oncologist who manages patients with PC, a pathologist specializing in pancreatic/GI cancers,
sequencing and bioinformatics experts, a radiologist focused on MRI research, and a biostatistician. This
project is innovative because the type of models proposed and the novel technologies that will be tested with
these models. The impact of validated porcine models of PC would be to enhance, complement, and
supplement preclinical data from other tumor models, and also to advance experimental technologies for PC
management to the clinic in a more efficient manner, with fewer experimental therapies failing in clinical trials.

Public health relevance
Porcine Platforms For Technology Development In Pancreatic Cancer PROJECT NARRATIVE The relevance of the proposed research to public health is that validated porcine models of pancreatic cancer should facilitate the development of new and more effective anti-cancer therapeutics. Secondary to its relatively large size, a porcine model of pancreatic cancer also will have utility in the development and/or refinement of devices/techniques to detect, image, diagnose, treat, and monitor these tumors.